CSHL Retroviruses Conference (2021-2024)

Retroviruses
Year 1 - May 24 – 29, 2021
Year 2 - May 23 – 28, 2022
Year 3 - May 22 – 27, 2023
Year 4 - May 20 – 25, 2024
This proposal seeks support for the forty-sixth, forty-seventh, forty-eighth and forty-ninth in an
annual series of meetings on “Retroviruses” to be held at Cold Spring Harbor Laboratory that
has emerged as the premiere conference for this field. The proposed meeting series will
assemble leaders in the field, junior faculty, postdoctoral fellows and graduate students to
discuss new, cutting-edge developments in the field of retrovirus biology. The meeting series is
focused on the viruses and their interactions with host cells rather than the particular diseases
they cause. The large majority of the work to be presented will be unpublished and subject to
immediate comment and discussion by the audience. Each meeting will be structured in a
manner that parallels the biology of the viruses; beginning with the entry phase of the replication
cycle, proceeding with post-entry events, including reverse transcription and integration, RNA-
related events (transcription, processing, export, and packaging), particle assembly and release,
pathogenesis/host factors, and concluding with antivirals and evolution. Selected speakers will
include graduate students, postdoctoral fellows and junior faculty from around the world. Each
session will be chaired by two leading scientists in the field selected by the organizers from
among the registrants. Two eminent invited speakers will give special lectures to inspire and
inform young scientists and to stimulate discussion between scientists working on related but
distinct areas. There will also be three poster sessions where a majority of participants can
present their work. Mentoring sessions for young scientists will address career development
issues including: finding the right postdoc; applying, interviewing, and negotiating faculty
positions; setting up your first lab; balancing responsibilities; primarily undergraduate
institutions; careers in industry; and, careers in scientific publishing. Each meeting will be of
moderate size, and we expect ~400 retrovirologists in attendance.

Public health relevance
Retroviruses 2021-2024 Narrative HIV/AIDS is now a major pandemic in human beings throughout the world. According to the World Health Organization, almost 80 million people have been infected with the HIV virus since the beginning of the epidemic, and almost 40 million people have died of HIV. Sub-Saharan Africa remains most severely affected, with nearly 1 in every 20 adults living with HIV and accounting for nearly 71% of the people living with HIV worldwide. Many conferences around the world address a plethora of issues related to the treatment of HIV/AIDS, but few do so by addressing the underlying biology of the virus, and even fewer do this by putting the molecular biology of the virus and its interaction with its human host in the broader context of how all retroviruses, irrespective of host, function and evolve. A key to the success of the Cold Spring Harbor annual retroviruses conference is that the majority of oral presentations are given by graduate students, postdoctoral fellows and junior faculty chosen on the basis of scientific merit, ensuring that the conference showcases the latest developments which are often yet to be published. Participants come from academic centers, research institutes and industrial centers around the world to present and discuss their findings. Many of the currently important treatments for HIV/AIDS were first presented or proposed at this conference in past years. Importantly, this application requests support for junior scientists who might not otherwise be able to attend to actively participate in the meeting. We are proposing to host four annual iterations of this important conference in spring 2021, 2022, 2023 and 2024.